BODY POSITION ON BREATHING &PULMONARY MECHANICS IN INFANTS

This study will evaluate whether an infant's sleeping position will influence the way the infant is breathing and the oxygen level in the body.